Supporting Relationships to Reduce Suicide Risk: A Randomized Control Trial of the Brief Relationship Checkup

Romantic relationship distress is a common impairment among Veterans struggling with depression,
posttraumatic stress disorder (PTSD), alcohol misuse, and suicide risk. In a study of Veterans who screened
positive for the above concerns in primary care, 58% of partnered Veterans reported romantic relationship
problems. Relationship problems are also a prominent risk factor for suicide, preceding 24% of Veteran suicide
deaths and 50% for Veterans 18-35. Conversely, full participation in mutually supportive relationships confers
protection against suicide. This suggests we may be able to offset risk by turning distressed relationships into
protective partnerships. Unfortunately, the intensive formats of existing couple therapies result in couples
discontinuing after 2-3 sessions or delaying treatment until they are close to breakup. This underscores the need
for brief relationship support that is accessible through primary care mental health (PC-MHI).
The Brief Relationship Checkup (BRC) is a three 30-minute session intervention to address relationship
distress. BRC incorporates a combination of couple therapy and motivational interviewing techniques to
encourage couples to make concrete commitments to improve their relationship. BRC demonstrates efficacy in
reducing suicide risk factors such as relationship dysfunction and promoting protective factors such as mutual
responsiveness to one another’s concerns, a core element of supportive relationships. Earlier Checkup programs
have also been shown to increase individual and couple therapy engagement and reduce depressive symptoms.
In an open label pilot trial, we found BRC was feasible and acceptable to Veterans screening positive on VHA
mental health primary screens. We also found its highly structured framework could be learned by trainees
without prior couple therapy experience.
RESEARCH PLAN: We propose a pilot randomized controlled trial (RCT) of BRC administered to 72 couples to
evaluate its ability to modify suicide risk/protective factors. Participants will be screened by phone to identify
couples that are in distressed committed relationship where at least one partner is a Veteran (the “Target
Veteran”) who screens positive on a primary care mental health screen for common suicide risk factors (i.e.,
suicide ideation, depression, PTSD, alcohol misuse). We will randomize couples to BRC or to three sessions of
the current PC-MHI Co-Located Collaborative Care model (CCC) for the Veteran partner only. All participants
will complete baseline, post-treatment, 3-month, and 6-month assessments. The study will provide the
foundations for a larger clinical trial proposal through pursuit of the following research aims and hypotheses (H):
AIM 1: Determine BRC’s efficacy in improving relationship factors related to suicide for both partners.
H1a. Couples in BRC will report greater reductions in relationship dysfunction than those in CCC.
H1b. Couples in BRC will report greater increases in mutual responsiveness than those in CCC.
AIM 2: Determine BRC’s efficacy in improving individual factors related to suicide for the Target Veteran.
H2a. Target Veterans in BRC will show greater therapy utilization via chart review than those in CCC.
Sub-aim 2b. Estimate associations between Target Veterans’ BRC participation and change in mental health
symptoms associated with suicide risk (i.e., depression; PTSD; and alcohol misuse).
Sub-aim 2c. Explore associations between change in risk factors and changes in Veteran suicide ideation.
AIM 3: Develop and validate a fidelity codebook to operationalize BRC adherence and clinician competency.
CAREER PLAN: Dr. Crasta will use each of the above research aims as an opportunity to pursue the
complementary training aims that were selected based on a prevention science framework:
Training Aim 1: Gain experience designing and conducting dyadic RCTs in a suicide prevention context.
Training Aim 2: Develop expertise in analyzing clinical trial data.
Training Aim 3: Learn the fundamentals of developing implementable interventions.

Public health relevance
Romantic relationship distress is a common impairment for Veterans screening positive for depression, posttraumatic stress disorder, or alcohol misuse in primary care. Relationship distress also serves as a prominent suicide risk factor. The Brief Relationship Checkup (BRC) is a three 30-minute session treatment that helps couples make concrete commitments to improve their relationships. We propose a pilot randomized controlled trial of BRC in 72 distressed couples (N=144 individuals) where at least one partner is a Veteran screening positive on a primary care mental health screen. Couples will be randomized to BRC or to three sessions of the Co-Located Collaborative Care model (CCC; the standard of care for primary care mental health). Couples will be re-assessed at post-treatment, 3-months, and 6-months. The results will provide the foundations for a larger trial by determining BRC’s efficacy in improving relationship-level and individual-level risk/protective factors for suicide. Finally, we will develop a fidelity codebook to operationalize BRC adherence and competence.